Investigating the role of T cells in promoting post-acute memory deficits after COVID-19 in mice

Project Summary
Millions of individuals in the United States suffer from post-acute symptoms of COVID-19 (PASC), many of
which are neurological in origin. Although SARS-CoV-2 does not cause widespread infection of the central
nervous system (CNS), significant neuroinflammation, decreased adult neurogenesis, alterations in synaptic
proteins, decreased total brain volume, and poor performance on tests of learning and memory have all been
observed in COVID-19 patients. However, the mechanisms by which a respiratory virus is causing persistent
neurological dysfunction are not well understood. Studies of PASC patients identified ongoing dysregulation of
T cell responses in the serum and imaging studies confirmed that PASC patients have activated T cells in the
CNS. Homeostatic T cells in the meninges are known to influence learning, memory, and anxiety-like behavior
through the secretion of cytokines, however the impact of T cells on neurological symptoms after COVID-19 is
unknown. Thus, I hypothesize that systemic inflammation promotes recruitment of antigen-specific T cells to
the CNS after SARS-CoV-2 infection, and these cells contribute to persistent deficits in learning and memory
via secretion of cytokines and other pro-inflammatory mediators. To investigate this, I will utilize my recently
developed mouse model of neurological dysfunction after COVID-19, in which intranasal infection of wild-type
mice with SARS-CoV-2 causes robust infection of the respiratory tract, but not the CNS, post-acute memory
deficits, loss of hippocampal neurogenesis, and increased pro-inflammatory cytokines in the CNS. Preliminary
data found that CD4+ T cells are recruited to the meningeal dura after infection and promote post-acute
memory deficits as determined via the Novel Object recognition test. In the K99 phase of this proposal, (Aim 1)
I will investigate the phenotype of CD4+ T cells in the CNS after SARS-CoV-2 infection and determine how
cytokines secreted by CD4+ T cells may contribute to memory deficits using a behavioral test battery and
investigation of neurogenesis and tri-synaptic circuit function. In Aim 2, I will test if T cell priming and
differentiation impact pathogenicity in the CNS after COVID-19 by first, determining if antigen specificity is
required for recruitment to and effector functions in the CNS and second, investigating which CD4+ T cell
effector subset is driving post-acute memory deficits. In the R00 phase, I will utilize a previously established
murine model of breakthrough vaccination to investigate how priming of CD4+ T cells in the periphery
influences differentiation into a pathogenic CD4+ effector subset. In Aim 3, I will explore how severe, systemic
inflammation may be driving recruitment of these pathogenic T cells to the CNS and which chemokine:
receptor pairs are critical for this process. Combined, this project will determine the mechanisms by which
pathogenic CD4+ T cells are recruited to the CNS after COVID-19 and how they promote post-acute learning
and memory deficits. These data could identify fundamental mechanisms by which immunity to viral infections
controls neurological function and potential druggable targets for treatment of PASC.

Public health relevance
Project Narrative Many COVID-19 patients suffer from post-acute neurological symptoms, such as learning and memory deficits, which may be driven by a dysregulated immune response to the SARS-CoV-2 virus. This project will investigate the mechanisms by which one of the body’s crucial, long-lived immune cell populations (T cells) may promote persistent learning and memory dysfunction after SARS-CoV-2 infection using a mouse model. These data will provide key insights into how immunity to a respiratory viral infection impacts neurological function and may identify potential druggable targets for treatment of patients with post-acute symptoms of COVID-19.